Regulation of TLR trafficking for proper self versus non-self discrimination

PROJECT SUMMARY
Inappropriate recognition of self nucleic acids (NA) by members of the Toll-like receptor (TLR) family can
result in autoimmune diseases such as lupus and psoriasis. TLR7 (and TLR8 in humans) and TLR9 can be
activated by self RNA and DNA, respectively, so defining the mechanisms that limit responses by these TLRs
is highly relevant to human health and disease. There is also accumulating evidence that the mechanisms
controlling TLR7 and TLR9 responses are distinct, but our understanding of the molecular bases for these
differences and their relevance for disease remain poor. This application is a renewal of the grant that has
funded our research studying the regulation of NA-sensing TLRs for 15 years. Our prior work helped to
establish the paradigm that multiple mechanisms operate to restrict the function of NA-sensing TLRs to
endosomes, which limits recognition of self NAs released from dead cells into the extracellular space. In the
last funding period, we made a major breakthrough that revealed a new mechanism mediated by the TLR
chaperone Unc93b1 that limits TLR7 responses to self RNA, and we showed that disruption of this mechanism
results in TLR7-dependent autoimmunity in mice. Intriguingly, this mechanism controls TLR7 but not TLR9.
Our prior discoveries raise many key questions that we aim to tackle in this renewal application. We do not
yet understand the molecular steps controlling the new mechanism of TLR7 regulation we discovered.
Moreover, we recently identified autoimmune patients with in-born coding variants in Unc93b1, but we do not
know if/how these variants cause disease. In this proposal we will also expand our studies of NA-sensing TLR
regulation beyond Unc93b1 based on recently completed genome-wide CRISPR screens for genes that limit
TLR7 and TLR9 responses. Both screens identified genes and pathways involved in core cell biological
processes, including endosome and lysosome regulation, underscoring the paradigm that the cell biology of
NA-sensing TLRs is critical to their regulation. However, the hits from the TLR7 and TLR9 screens are almost
completely non-overlapping, providing exciting mechanistic insights into how these receptors are distinctly
regulated. Based on these results, we propose 3 Specific Aims. Aim 1 will define the key steps by which
Unc93b1 limits TLR7/8 responses and will test whether the human coding variants we have identified disrupt
these steps. Aim 2 will characterize results from a genome-wide CRISPR screen that identified the cellular
machinery and pathways limiting TLR7 responses to self RNA. Aim 3 will focus on TLR9 and begin to define
the mechanisms that limit TLR9 responses to self DNA.
The overall impact of this application comes from the central role that NA-sensing TLRs play in
autoimmunity and from the benefit gained by defining the mechanisms that limit responses to self NA. Our
central premise is that defining the mechanisms that regulate TLR7 and TLR9 will uncover their distinct roles in
autoimmune diseases and enable more effective therapies.

Public health relevance
PROJECT NARRATIVE Inappropriate responses to self nucleic acids by immune receptors called Toll-like receptors (TLRs) can lead to autoimmune diseases such as lupus, psoriasis, and rheumatoid arthritis. What goes wrong to enable such responses in certain individuals who develop disease remains unclear. This application focuses on the discovery of new mechanisms that when disrupted promote responses to self nucleic acids by TLRs and drive autoimmune disease.